MACS/WIHS Combined Cohort Study: Brooklyn Clinical Research Site (Bklyn CRS)

PROJECT SUMMARY
This project will establish and implement the Brooklyn Clinical Research Site (Bklyn CRS) of the MACS/WIHS
Combined Cohort Study (MACS/WIHS CCS) and support its mission to advance the clinical, behavioral, and
epidemiological science of newly diagnosed and chronic HIV infection and associated comorbidities. The Bklyn
CRS evolves from and builds upon a 25-year history of scientific innovation accompanied by community
engagement that facilitated rigorous implementation of the Brooklyn Women's Interagency HIV Study (WIHS).
The Bklyn CRS will rapidly develop a diverse cohort of men and women reflecting the unique characteristics of
HIV in our geographic area. We will include continued follow-up of WIHS participants, who contribute a rich
longitudinal history of clinical, biologic, genetic, psychosocial and behavioral data derived from midlife and
younger ages, informing questions of HIV and aging in an older population. The Bklyn CRS investigators will
develop and implement protocols of the MACS/WIHS CCS Unified Science Agenda, contribute to the overall
functioning of the administrative infrastructure, and engage a strong and multidisciplinary team of researchers
in addressing innovative science.
Our specific aims are to: 1) recruit and retain a prospective cohort of 500 men and women living with HIV and
matched seronegative controls and implement MACS/WIHS CCS study protocols; 2) engage a
multidisciplinary and experienced team of scientists to develop and implement innovative research that aligns
with and advances the CCS Unified Science Agenda; and 3) provide training and career development
opportunities to support advancement of the next generation of HIV researchers.
The Bklyn CRS provides scientific, administrative and collaborative leadership in cardiovascular disease and
associated lung and sleep outcomes; aging via physical, functional and molecular assessments; psychological
and social environmental aspects of self-management of HIV and associated co-morbidities; and
neurocognition and brain aging. As such, the Bklyn CRS will greatly enhance the MACS/WIHS CCS, ensuring
the rigor and relevance of study questions and methods to address those questions.

Public health relevance
PROJECT NARRATIVE The Bklyn CRS of the MACS/WIHS CCS will address the unique and diverse characteristics of aging, urban, underrepresented men and women, and examine critical questions regarding clinical, behavioral, and epidemiological characteristics of HIV infection and associated comorbidities through follow-up of a cohort of men and women with HIV infection and matched seronegative controls. This platform will ultimately inform policy, treatment, and prevention approaches that will improve the health and well-being of men and women living and aging with HIV infection.